Core C: Biospecimen and Biomarker Core

CORE C: SUMMARY
The Biospecimen and Biomarker Core C of the Yale SPORE in Lung Cancer (YSILC) has and will focus on the
continuous acquisition, processing and analysis of high-quality blood and tissue samples from patients with lung
cancer, as well as the development and execution of robust biomarkers to support the main YSILC projects and
the Career Enhancement and Developmental Research Programs projects. This shared resource will continue
to provide access to unique samples and sample derivatives, perform systematic quality control procedures to
secure scientific rigor, enhance the technical skills and capacities beyond the individual projects, and ensure
consistency and reproducibility across YSILC activities. The mission of Core C is to maximize the scientific
quality and output of the YSILC projects by providing highest quality biospecimens backed up by rigorous
molecular analysis using both conventional and next generation technologies. The biospecimen operations will
specialize in the acquisition, processing, storage, annotation, quality control and distribution of samples from
lung cancer patients including primary (unmodified) specimens and secondary (modified) tumor samples
including tissue microarray-based cohorts, “live” single cell suspensions and fresh tumor-associated primary
explants. The biomarker activities will include providing access to comprehensive biomarker capacities and
tissue analysis services including multidimensional quantitative measurements of proteins and nucleic acids from
solid and liquid specimens. This Core is co-led by Drs. Kurt Schalper and David Rimm, both with unique and
complementary expertise. Dr. Schalper brings knowledge in biospecimen collection, molecular pathology, tumor
immunology, correlative clinical trial studies and the generation of ex vivo tumor models. Dr. Rimm brings
expertise in quantitative pathology, biospecimen science, spatial biomarkers and regulatory aspects. The specific
aims are: Aim 1: To collect, maintain and distribute high quality biospecimens for use in Projects 1-3,
Developmental Research and Career Enhancement Programs projects; Aim 2: To develop and distribute
advanced secondary biospecimens to support Projects 1-3 and other YSILC activities; and Aim 3: To conduct
or assist in molecular pathology analyses of biospecimens including quantitative protein analysis and high-plex
discovery.